Biostatistics

PROJECT SUMMARY/ABSTRACT
The Biostatistics Shared Resource (BiostatSR) supports the Sidney Kimmel Comprehensive Cancer
Center (SKCCC) to ensure that study designs, data procedures and analyses of study data use state-of-the-art
methods that provide an accurate and reproducible summary of the study results, including associated
uncertainties, and to help SKCCC researchers garner peer-reviewed funding. The BiostatSR, established in
1986, received its first CCSG funding as a Shared Resource that year. The BiostatSR continues close
collaborations with SKCCC Members, providing expertise in study design, data analysis, regulatory and interim
reporting (e.g., data safety and monitoring reports), manuscript writing, and development of new biostatistical
methods and study designs required by a project or benefiting multiple SKCCC investigators. The BiostatSR
also supports creation of information systems to support individual or Research Program efforts.
In addition to being strongly integrated into all Programs in the SKCCC, BiostatSR biostatisticians have
important intellectual ties to other units at Johns Hopkins Medicine, such as the Department of Biostatistics in
the Bloomberg School of Public Health. This diverse environment provides SKCCC investigators with strong,
broad-based biostatistical expertise.
The BiostatSR hired several members during the current grant cycle and continues to provide outstanding
support to the SKCCC. During this past funding cycle, the BiostatSR continued to function with faculty and staff
aligned with SKCCC Research Programs and disease groups. BiostatSR members attend regular meetings
with their programmatic colleagues and are available for consultation on laboratory investigations and clinical
studies in those programs. For example, the BiostatSR supports SPORE grants and Program project grants
involving faculty and staff in both preclinical and translational investigations in many areas. BiostatSR
members have increased the level of collaboration with study coordinators in the development of case report
forms and protocol-specific databases to ensure that subsequent analyses will faithfully present study data.
SKCCC Managed Shared Resource
Reporting Period: January 1, 2020 to December 31, 2020